miRNA buffering mechanisms and phenotypic variability in genetic syndromes

PROJECT SUMMARY
The developing embryo has the remarkable ability to buffer insults, ensuring normal development in the face of
genetic and environmental influences. But when these insults exceed a disease threshold - birth defects can
result. Our goal is to elucidate how these buffering systems mediate the interplay between genes and
environment and if disruption of these buffering systems contributes to structural birth defects in genetic
syndromes. Resistance to perturbations is known as developmental robustness, and miRNA-mediated
negative feedback loops potentially play critical roles in buffering genetic and environmental insults. Disruption
of miRNAs results in increased sensitivity to environmental factors in model organisms; yet, whether the
miRNA-mediated buffering mechanisms play a role in birth defects remains unknown.
This proposal will investigate whether defective miRNA-mediated buffering drives the phenotypic variability in
22q11.2 deletion syndrome (22q11DS). 22q11DS is the most common deletion syndrome in humans, with
variable features independent of the size of the deletion. It is well accepted that variability is due to the
influence of genetic and environmental modifiers, but the identity of these factors still needs to be discovered.
Preliminary data indicate that mouse models of 22q11DS exhibit abnormal vitamin A/Retinoic acid signaling
regulation, and dietary supplementation of the maternal diet with vitamin A (within recommended levels for
pregnancy) is a modifier of outflow tract (OFT) defects in a mouse model of 22q11DS. Furthermore, Dgcr8 is
deleted in 22q11DS. Due to its essential role in synthesizing mature miRNAs, Dgcr8 is an exciting but
unexplored candidate for mediating abnormal buffering of signal transduction pathways in 22q11DS.
This proposal aims to test the hypothesis that maternal dietary intake of vitamin A is an important modifier of
OFT defects in 22q11DS, potentiated by the altered capacity of the 22q11DS embryo to buffer changes in
vitamin A intake. We propose that reduced buffering capacity transforms benign vitamin A exposures into
teratogenic doses by failing to rapidly engage miRNA-mediated negative feedback mechanisms to buffer
retinoic acid signaling. Moreover, Tbx1 is deleted in 22q11DS and implicated in congenital heart defects
(CHDs) in 22q11DS. However, the haploinsufficiency of Tbx1 results in low penetrance of OFT defects. We
propose that altered buffering capacity in 22q11DS amplifies RA signaling and reduces Tbx1 gene dosage
below a threshold needed for proper OFT development. This novel mechanism for aberrant gene-environment
interactions will be tested with two specific aims: To establish (1) how RA buffering is disrupted in 22q11DS;
and (2) if reduced miRNA processing due to Dgcr8 haploinsufficiency mediates altered RA buffering and
contributes to OFT defects in 22q11DS. Together, these experiments will provide a novel understanding of the
mechanisms mediating gene-environment interactions. This new insight can directly translate to preventing
structural birth defects in 22q11DS.

Public health relevance
PROJECT NARRATIVE We propose investigating whether defective miRNA buffering underlies the phenotypic variability observed in 22q11.2 deletion syndrome. The results of these experiments will provide a new mechanistic understanding of the interaction of genes and environment, which can be directly translated to the prevention of congenital disabilities in 22q11.2 deletion syndrome.